Desirability Of Outcome Ranking (DOOR) Analyses for the NICHD MFMU and MOMS Studies

The Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD) Maternal
Fetal Medicine Units (MFMU) Network was set up in 1986 and continues to conduct major practice-changing
clinical trials in maternal and fetal medicine. Primary results of the MFMU Network’s trials have amassed over
7,400 citations (average 320 citations per primary manuscript) and are frequently referenced in the American
College of Obstetricians and Gynecologists Practice Bulletins. The NICHD also supported the Management of
Myelomeningocele Study (MOMS), a groundbreaking trial of surgical repair of the spina bifida defect before the
baby is born versus the usual postnatal surgical repair and the follow-up study of the children (MOMS2).
Results from obstetrical clinical trials can be challenging to understand and inform clinical practice since the
effects of an intervention on the outcomes of the birthing individual and their perinate may be discordant. For
example, for any individual trial participant and their perinate (dyad), an obstetrical intervention may improve a
perinatal outcome but worsen a maternal outcome. In practice, this imbalance of benefit may increase the
complexity of decision-making and back-and-forth discussions between clinical provider and patient due to
various understandings and perceptions of treatment strategies and outcomes for the pregnant person or
perinate.
The Desirability Of Outcome Ranking (DOOR) is a paradigm shift for the design and analysis of clinical trials
that can consider both maternal and perinatal outcomes concurrently to comprehensively and objectively
evaluate the effects of interventions on the overall success of the pregnancy. The partial credit strategy, part of
the DOOR analysis, assesses the robustness of trial results which further allow any individual to evaluate
results with respect to their own perspective on outcomes.
The primary goal of this research project is to utilize the DOOR methodology to generate and disseminate
clearer and more meaningful interpretations of trial results to advance understanding from these NICHD
funded studies (MFMU and MOMS) that have informed clinical practice. Providing more interpretable results is
the fundamental basis for understanding how interventions lead to healthier pregnancy and infant outcomes,
both of which are topics directly related to the NICHD’s mission. Results from these DOOR analyses of existing
high-impact studies will enhance the global understanding of how obstetrical interventions lead both the
birthing individual and their perinate towards healthier and desirable outcomes and will provide the
foundational education and knowledge for future obstetrical trials.

Public health relevance
This initiative will generate and disseminate results from high-impact and practice-changing obstetrical trials supported by the Eunice Kennedy Shriver National Institute of Child Health and Human Development to provide a detailed understanding of the pregnant individual and perinate’s response to treatment for enhanced clinical decision-making through the use of novel methodology: Desirability Of Outcome Ranking (DOOR). An innovative use of DOOR methodology for obstetrical trials consists of analyzing dyad-centric outcomes from the pregnant individual and their perinate concurrently. This approach produces more informative results and more meaningful interpretations than traditional separate evaluations of maternal and perinatal outcomes; and the results provide a comprehensive evaluation and an intuitive interpretation of the effects of obstetrical interventions on the birthing individual and the infant, and will set the foundation for future obstetrical trials that simultaneously prioritize healthier pregnancy and infant outcomes.